NARMS Laboratory Portal

Project Summary/Abstract
EJH & Associates, LLC (Datastream Connexion) proposes the development and operations
of a NARMS portal based on a collaborative suite of online tools called LabSUITE, which
includes laboratory speciﬁc technology and functions. LABSuite is used successfully in
other federal lab and can successfully facilitate NARMS needs, including cross agency
information dissemination.
The NARMS LABSuite portal capabilities would include customized working groups, web-
based proﬁciency testing registration and management, and tools that support secure
information sharing among animal and human health, retail foods, veterinary diagnostic
and other stakeholders. Collectively, the LabSUITE & GovSuite combined platform tools is
a sustainable model built and operationalized for secure communication, coordination,
collaboration, education, and training among stakeholders charged with protecting the
nation's critical infrastructures such as food and agriculture. This proposal focuses on two
main objectives:
· Develop tools that advance the National Antimicrobial Resistance Monitoring
System (NARMS) laboratories’ capacity to respond events through eUicient online
data capture and management of laboratory capabilities and proﬁciency testing
results.
· Facilitate secure information sharing and communication for enhanced animal and
public health.
LabSUITE tools allow professionals working in diUerent organizations (e.g. government,
academia) to work together on essential missions and responsibilities despite diUerences
in authorities, objectives, and roles. This robust platform connects the community
stakeholders to a centralized online environment and houses databases of current
information related to the mission of the NARMS to include but not limited to laboratory
testing protocols, facilities, equipment and professional expertise and contacts. Current
LabSUITE Information Sharing Environments (ISEs) include the Food Emergency Response
Network (FERN- https://www.fernlab.org) and the APHIS Laboratory Portal
(https://www.nahln.org), formerly called the National Animal Laboratory Network Portal,
and Vet-LIRN (https://www.vetlirn.org).
The work is critical as FDA, CDC, and USDA jointly monitors the capability and
performance of state, and university diagnostic laboratories to respond to threats, Monitor
trends in antimicrobial resistance among enteric bacteria from humans, retail meats, and
animals at the time of slaughter; Conduct research to better understand the emergence,
persistence, and spread of antimicrobial resistance; and Provide timely antimicrobial
resistance data for outbreak investigations.

Public health relevance
NARMS Project Narrative EJH & Associates, LLC (Datastream Connexion) propose to deploy and customize a Laboratory services and Knowledge Management Portal utilizing the LABSuite, a GovCloud-based Software as a Service platform to optimize and improve the sharing of animal health, veterinary diagnostics, human health and retail food information, laboratory capabilities, along with research projects within the NARMS network. The methods utilized by the LABSuite tools will improve the capabilities and capacity of laboratories to investigate potential animal foodborne illness outbreaks or contamination events. This project in its first phase will leverage the existing LABSuite platform, in particular the laboratory directory (Lab-DIR) and Proficiency Testing Results Capture system (PT Module) utilized by the Food Emergency Response Network (FERN), the APHIS Laboratory Network portal, formerly called the National Animal Laboratory Network (NAHLN) portal, and Vet-LIRN.